Non-Syndromic Hearing Loss -- A Collaborative Study

DESCRIPTION (provided by applicant): Advances in the molecular genetics of deafness have vastly improved our ability to identify heritable hearing losses. Most familial moderate-to-profound congenital losses are inherited as an autosomal recessive trait. Heterogeneity is high, and to date 77 non-syndromic recessive loci have been identified and numbered sequentially DFNB1 through DFNB77 (DFN, deafness;B, recessive;integer, order of discovery). Twenty-eight causally-related genes have been cloned and encode proteins with a wide range of functions. Mutations in one gene, GJB2 at the DFNB1 locus, are responsible for half of moderate-to-profound autosomal recessive non-syndromic deafness (ARNSD) in many developed countries, making DFNB1 the most common type of hereditary congenital hearing loss. Mutations in SLC26A4 at the DFNB4 locus rank second and are associated with a Pendred Syndrome (PS)-DFNB4 phenotype. In aggregate, these advances have numerous important consequences. First, the identification of genes essential for normal auditory function has provided valuable insight into inner ear physiology at the molecular level and may one day lead to the development of novel therapies to treat deafness. Second, the use of genetic testing to diagnose ARNSD has changed the medical evaluation of the deaf person. Third, the identification of numerous genes that cause ARNSD, coupled with recent technological advances in microarray sequence capture and deep sequencing, is now making epidemiological studies of genetic deafness possible for the first time. This renewal application will focus on these three areas by completing specific aims: (1) To identify novel ARNSD genes;(2) To complete mutation screening of all genes implicated in non-syndromic deafness;(3) To study PS-DFNB4 as a complex disease. Completion of these specific aims will not only increase our understanding of the biology of hearing and deafness, but will be highly translational by improving the clinical diagnosis of non-syndromic deafness. PUBLIC HEALTH RELEVANCE: Autosomal recessive non-syndromic deafness (ARNSD) is extremely heterogeneous. To date 77 loci have been identified and 28 causally-related genes have been cloned. Studying these genes will increase our understanding of deafness, improve patient care, and ultimately lead to novel methods of treating ARNSD.

Public health relevance
Autosomal recessive non-syndromic deafness (ARNSD) is extremely heterogeneous. To date 77 loci have been identified and 28 causally-related genes have been cloned. Studying these genes will increase our understanding of deafness, improve patient care, and ultimately lead to novel methods of treating ARNSD.